RISK FACTORS ASSOCIATED WITH PRIMARY CMV INFECTION IN RHESUS MACAQUES

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Viral and immune factors associated with primary transmission of CMV infection including breast milk transmission are being examined in infant and juvenile rhesus macaques. AIDS related.